A novel circuit underlying amotivation in a mouse model of 22q11DS

PROJECT SUMMARY (See instructions):
The work proposed in the R00 phase of this project will be completed at the University of Tennessee
Health Science Center in Memphis, TN.
Schizophrenia is a multifaceted neurodevelopmental disorder characterized by positive, cognitive, and
negative symptom categories. One particular negative symptom, amotivation, generates a major impact on
public health, yet the treatment options for this symptom remain sparse. This proposal seeks to investigate
a novel circuit underlying the amotivation phenotype in a mouse model of 22q11 deletion syndrome
(22q11DS), one of the most robust genetic contributors to schizophrenia. Data derived from this study
stand to provide novel treatment options aimed at rectifying amotivation. Despite being implicated in
motivational states, the dorsal striatum is largely overlooked when studying motivated behavior. Moreover,
disruptions in thalamic nuclei are involved in all facets of schizophrenia symptomology, but the role of the
thalamus in amotivation remains unknown. My preliminary results demonstrate amotivation in 22q11DS
mice, as well as a deficit in synaptic transmission in the thalamostriatal pathway. Information flow through
this circuit is modulated by intra-striatal cholinergic interneurons. In 22q11DS mice, I find that there is an
increase in the number of spontaneously active cholinergic interneurons and that blocking cholinergic
transmission rescues the thalamostriatal synaptic deficit. These findings are the first to implicate the
thalamostriatal circuit and cholinergic signaling in motivated behaviors. To study this further, I propose to
use cutting-edge approaches in three aims of investigation: 1) to determine the role of striatal cholinergic
interneuron activity in amotivation, 2) to elucidate the cholinergic mechanism underlying weakened
thalamostriatal synaptic transmission, and 3) to identify the contribution of distinct striatal microcircuits in
amotivation. The results of this study stand to significantly enhance our understanding of the neural circuits
underlying motivated behaviors and provide important insight into the disruption of motivation that occurs in
neuropsychiatric disorders such as schizophrenia, depression, and addiction.

Public health relevance
RELEVANCE (See instructions): The intractable amotivation symptom in schizophrenia generates a debilitating condition with a substantial public health burden due to a lack of mechanistic understanding of the underlying neural circuits. The proposed research will use a genetic mouse line to selectively isolate and pinpoint a novel circuit that underlies the amotivation phenotype. The results of these experiments are positioned to provide a circuit-specific mechanism that can be manipulated to help inform therapeutic strategies to alleviate amotivation in patients.